Developing macrophage-based therapies for peripheral nerve injuries

Summary
Peripheral nerve injuries, whether the result of trauma, surgical complications, or neuropathies, afflict millions
of people in the United States alone and are a major cause of disability and suffering throughout the world. The
symptoms of peripheral nerve injury include numbness, tingling, muscle weakness, pain, and gait dysfunction.
Despite the critical need, there are currently no approved therapies to accelerate peripheral nerve regeneration
following injury. Though many researchers are focusing their investigations of nerve injury on components of
the peripheral nerve itself, particularly neurons and Schwann cells, we have taken a novel approach and are
focusing on components of the immune system-- specifically macrophages. Immunotherapy, or the
manipulation of the immune system to treat human diseases, is a rapidly growing area in medicine that has
shown great promise, particularly in treating autoimmune diseases and cancer. Immunotherapies can take
many forms, including monoclonal antibodies, checkpoint inhibitors, and regulatory T lymphocyte transfusions.
Though not currently used for treating human diseases, macrophages could also be harnessed to treat select
diseases, with peripheral nerve injuries being a potential target due to disruption of the blood-nerve barrier and
the established role of macrophages in peripheral nerve regeneration. Building on research demonstrating the
importance of metabolism for the function of macrophages, we
are studying the impact of alterations in a
critical metabolic transporter, monocarboxylate transporter 1 (MCT1), on the function of macrophages. We
recently published a paper showing that downregulation of MCT1 selectively in macrophages impairs
phagocytosis, reduces production of pro-regenerative cytokines, and impairs recovery from peripheral nerve
injury. More importantly from a clinical perspective, we also found that upregulation of MCT1 selectively in
macrophages accelerates peripheral nerve regeneration and that macrophages injected intravenously into
mice target the injured nerve and participate in repair. Based on these results, our current proposal will
investigate two potential mechanisms for accelerating nerve recovery from injury in mice. In Aim 1, we will
transform macrophages ex vivo to upregulate MCT1 or pro-regenerative pathways with lipid nanoparticles
expressing MCT1 plasmid or encapsulating baicalin, respectively, and test whether adoptive cell transfer of
these transformed macrophages accelerates nerve repair and recovery. In Aim 2, we will test whether these
same lipid nanoparticles are capable of transforming macrophages in vivo following direct intravenous
injections, resulting in accelerated recovery from peripheral nerve injuries. If successful, the experiments in this
proposal will not only validate a novel technique and target for accelerating nerve recovery following injury, but
also potentially provide an agent for manipulating macrophages in other macrophage-dependent conditions,
such as non-healing skin wounds, pulmonary or liver fibrosis, and muscle injuries.

Public health relevance
Narrative We recently found that upregulation of monocarboxylate transporter 1 (MCT1) selectively in macrophages in transgenic mice accelerates peripheral nerve recovery following injury and that macrophages injected intravenously into mice target the injured nerve and participate in repair. In this proposal, we will develop and test the capacity of lipid nanoparticles that upregulate MCT1 or pro-regenerative pathways in macrophages to enhance recovery from nerve injury following infusion of either macrophages treated with these lipid nanoparticles or the lipid nanoparticles themselves. Through these studies, we hope to validate new tools for accelerating nerve regeneration and provide important pre-clinical data for macrophage-directed treatments of peripheral nerve injuries.